NSR-GENE (Neonatal Seizure Registry, GEnetics of post-Neonatal Epilepsy)

PROJECT SUMMARY
Neonatal seizures due to brain injury (acute symptomatic seizures) are associated with high risk of post-
neonatal epilepsy. Although clinical risk factors can help predict which children are at highest risk for epilepsy,
little is known about how genetic factors modify the risk for epilepsy after acute symptomatic neonatal seizures.
The proposed “Neonatal Seizure Registry – GENetics of Epilepsy (NSR-GENE)” study will test the central
hypothesis that children who develop post-neonatal epilepsy are more likely to have pathogenic variants in
epilepsy genes, and enrichment in single nucleotide polymorphisms within key inflammatory, neurotransmitter
transport and homeostasis, and neurotrophic gene pathways as compared with children who do not develop
unprovoked seizures before age five years, and that these can be added to traditional clinical risk factors to
predict epilepsy after neonatal seizures.
This observational study leverages the infrastructure of the nine center Neonatal Seizure Registry, to which we
have recruited >300 children with acute symptomatic neonatal seizures (NCT02789176, NCT04337697). This
unique cohort of children and their parents will be invited to participate in non-invasive genetic testing. Using
neonatal clinical, EEG, and MRI measures available through the Registry, along with genetic testing results,
we will build robust models to predict risk of epilepsy and elucidate mechanisms of epileptogenesis.
We will test our hypotheses by pursuing the following specific aims: Aim 1: Determine whether there is an
increased incidence of pathogenic coding SNVs and gene rich CNVs within epilepsy genes among children with
acute provoked neonatal seizures and post-neonatal epilepsy compared to those without subsequent epilepsy;
Aim 2: Determine whether an increased incidence of non-coding SNPs with a priori linkage to epilepsy is
associated with the risk of post-neonatal epilepsy; Aim 3 Develop prediction rules to stratify neonates based on
risk for post-neonatal epilepsy.
This innovative proposal will maintain an existing, multicenter cohort enrolled from US centers that employ
state-of-the-art technology for diagnosis and investigation of neonatal seizures, and targets research priorities
of parents and clinicians. This carefully designed study will provide novel, clinically relevant answers to key
questions about epilepsy in this highly vulnerable patient population. Results will inform the subsequent design
of intervention studies and programs designed to reduce the risk of epilepsy after early life seizures.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the results will have immediate positive impact for children with neonatal seizures due to early brain injury, their families, and the providers who care for them. Through this study, we will take innovative steps to understand the multifaceted genetic contributors to epilepsy after neonatal seizures. The proposed research is directly relevant to the NIH mission, which calls for the development of methods to enhance health and reduce illness and disability, to seek fundamental knowledge about the brain and nervous system, and to use that knowledge to help all children to achieve their full potential through reduction of the burden of neurological disease.